Personalized Quality of Life Measurement

PROJECT SUMMARY/ABSTRACT.
A lack of outcome-focused quality measures is holding back mental health (MH) progress. This gap means that
regulatory bodies and third-party payers do not have a “common denominator” that they can use to compare
the impact of MH symptoms and treatment options across all MH and physical health (PH) conditions. For
example, we cannot effectively compare the overall impact of treatment for depression to treatment for other
MH conditions such as schizophrenia, or to PH conditions such as diabetes. Quality measurement also
underpins cost-effectiveness research, and as a result we cannot accurately allocate resources needed for a
nationwide MH strategy. Furthermore, clinicians and researchers cannot recommend treatments based on
overall impact, but rather they are restricted to narrowly focused symptom and outcome measurements.
Without addressing problems in outcome-focused quality measures, patients will continue to face a disjointed
MH care system where sufficient resources are not apportioned to their needs, their clinicians cannot select
treatments in a way that will maximize their overall functioning, and research to improve their care cannot
consistently demonstrate comparative effectiveness.
Quality of life (QOL) measures provide a promising approach to serve as a common denominator for outcome-
focused quality measurement across conditions. However, current nomothetic approaches are not specific to
MH symptoms, which creates measurement insensitivity and substantially reduces measurement accuracy.
There are also many idiographic QOL measures that are tailored to specific disorders, but they are not directly
comparable across MH or PH conditions. New QOL measurement approaches are needed that are both
nomothetically comparable across disease conditions and ideographically tailored to MH phenomenology.
New developments in unsupervised machine learning (ML) are well suited to address these limitations in QOL
measurement. Specifically, we will use recent advances in mixture modeling to create a new personalized QOL
measurement approach that simultaneously produces both nomothetic and idiographic results. The proposed
project is significant and impactful because it eliminates a critical bottleneck to efforts by policy makers,
researchers, and clinicians. Results from this work will allow all of these stakeholders to better discern
differential impact among MH conditions and interventions. As a result, they will be able to better serve patients
who experience MH difficulties. This project is also scientifically and methodologically innovative. It creatively
uses new developments in unsupervised ML to implement a new measurement process while minimizing
disruption to current practices. Overall, the proposed project will provide a new standard for outcome-focused
measurement of MH care.

Public health relevance
PROJECT NARRATIVE. Without addressing problems in outcome-focused quality measures, policymakers, researchers, and clinicians are limited in their ability to detect the impact of mental health on society and the efficacy of interventions intended to ameliorate this impact. To address these problems, we propose a creative new approach to measuring quality of life that can serve as a more accurate and generalizable outcome-focused quality measure. As a result, the proposed research is relevant to public health because it eliminates a critical bottleneck to efforts by policy makers, researchers, and clinicians who are looking to improve mental health outcomes.